Estrogen and TMJ Pain

DESCRIPTION (provided by applicant): Women report greater temporomandibular joint (TMJ) pain when the concentration of estrogen is diminishing. Consistent with these results, estrogen reduces TMJ hypersensitivity in proestrus rats, when estrogen concentrations are highest. In our lab, a large gene array study (>10,000 genes) indicated that gene expression in the rat trigeminal ganglia (TG) was significantly affected by increased estrogen. High proestrus versus low diestrus levels of 17ß-estradiol resulted in a 16 to 34 fold increase in the GABAA receptor subunit α6 (Gabrα6), the glycine receptor subunit α2 (Glrα2) and the beta-adrenergic receptor subunit ß1 (Adrß1). This significant increase occurred in the TG of naïve rats and in rats with ligature of the masseter tendon, a model of chronic (>6 months) myogenic TMJ hypersensitivity. Since GABA, glycine and sympathomimetic amines can inhibit hypersensitivity the knock-down of Gabrα6, Glrα2 and Adrß1 expression would be expected to increase hypersensitivity. In preliminary studies siRNA knock-down of Gabrα6 expression in the TG increased hypersensitivity, increased the level of phosphorylated-ERK (p-ERK) in TG neurons and increased neuronal electrical activity. A homology search for estrogen receptor α and ß (ER α and ERß) binding sites 10kb of the transcriptional start site for these three genes showed that at least one potential binding site was present but the mechanism regulating the estrogen response of these genes is unknown. Based on this information we hypothesize that 17 ß-estradiol decreased TMJ hypersensitivity at proestrus by increasing Gabrα6, Glrα2 and Adrß1 expression in the TG and that this estrogen effect was due to interaction with the estrogen receptor and sequence proximal of the transcriptional start site. To address this hypothesis we propose two specific aims, in Aim #1 we will determine in the TG the role of Gabrα6, Glrα2 and Adrß1 in modulating TMJ hypersensitivity/cellular activity in both males and females. To complete aim #1 a ligature will be placed on the masseter tendon and TG expression of Gabrα6, Glrα2, and Adrß1 will be reduced through antagonists or siRNA. Hypersensitivity/cellular activity will be assessed at an acute stage (7 days post-ligature) and at a chronic stage (6 months post-ligature) using von Frey filaments, meal duration, electrophysiological recordings and by quantitating p-ERK levels. The goal of Aim #2 will be to characterize the role of ERα and ERß in controlling Gabrα6, Glrα2, and Adrß1 expression using chromatin immunoprecipitation, electrophoretic mobility shift assays and luciferase reporter constructs. We expect to show that an altered expression of these three genes can affect the TMJ nociceptive response and that these genes are responsible, in part, for the decrease in hypersensitivity observed in proestrus rats. We also expect to determine the mechanism by which estrogen modulates expression of these genes in TG cells.

Public health relevance
Novel genes by which 17ß-estradiol effects TMJ hypersensitivity will be identified, providing a greater understanding of why females suffer greater TMJ pain and allowing for targeted control of expression to reduce orofacial pain.